Leveraging data synthesis to identify optimal and robust strategies for HIV elimination among substance-using MSM

Project Summary
Alcohol and methamphetamine use increases risk of HIV among men who have sex with men (MSM) and
numerous interventions have been developed to decrease HIV acquisition and transmission among substance
using MSM. Yet, despite a considerable body of research documenting these associations, substantial
uncertainty remains regarding the specific behavioral pathways between substance use and HIV that are most
responsible for this elevated risk (e.g., condom use, sexual partner selection, or HIV medication adherence).
Without this knowledge, it is difficult to identify the extent to which substance use drives HIV among MSM or
estimate the population level impact of interventions among substance using MSM. In addition, substance use,
adherence, risk reduction, and combined interventions have all shown excellent promise to reduce HIV
incidence, but large-scale comparative effectiveness trials are extremely challenging and costly and can
seldom comprehensively examine the unique value of these interventions to specific subgroups (e.g., by
race/ethnicity or age). Accordingly, this project seeks to 1) synthesize data on the relationship between alcohol,
methamphetamine, and HIV among MSM, including the impact of substance use on HIV risk behavior and the
prevention-care continuum, 2) estimate the plausible range and sources of HIV infections attributable to
alcohol and methamphetamine use among MSM using a principled and widely-used approach to network
epidemic models (i.e., EpiModel), and 3) determine optimal and robust strategies for reducing HIV incidence
among substance using MSM. For each aspect of this work, we will leverage advanced statistical and
computational tools to rigorously calibrate our models, validate them against independent data sources, and
perform extensive sensitivity analysis. To increase the usefulness of these models for real-world decision
making, we will utilize uncertainty quantification to ensure the identified strategies are most likely to succeed
after accounting for potential inaccuracy in our model parameters and assumptions. All model development will
be conducted using open-source software enabling easy replication, modification, and extensions by other
researchers. The project's team is exceptionally well positioned to achieve these goals with expertise spanning
network analysis, drug use epidemiology, epidemic modeling, and high-performance computing. Finally,
dissemination activities are designed to directly inform key stakeholders in order to reduce HIV incidence and
maximize the impact of this project on HIV elimination efforts.

Public health relevance
Project Narrative Alcohol and methamphetamine use are associated with increased HIV risk among men who have sex with men (MSM) but the precise behaviors most responsible for this elevated risk are not well understood. This study will integrate data from several large cohort studies to parameterize network epidemic models and provide holistic estimate of the effect of these substances on HIV incidence among MSM. Subsequently, we will leverage these models as an experimental laboratory to evaluate the population level impact of substance use and HIV interventions among MSM, utilizing cutting-edge computational tools to identify robust and optimal interventions for HIV elimination.